UC San Diego Genetics Training Program

The UC San Diego Genetics Training Program (GTP) is designed to provide advanced
training in Genetics and Genomics to predoctoral students beginning in their second
graduate year. While several degree-granting umbrella programs at UCSD include
genetics or genomics research, GTP uniquely integrates trainees across programs and
builds both lateral and vertical cohorts of PhD students interested in the history, practice
and future applications of Genetics and Genomics in life and health sciences. Mentor
laboratories encompass a broad range of basic science and clinical/translation research
and span a range of organisms–including microbial, plant, experimental animal, and
human subjects–but share a focus on genetic, genomic, and epigenomic mechanisms
and approaches. Students who have committed to thesis research in one of these
laboratories enter the GTP for advanced training activities after the first year and may be
selected for support by this training grant. The GTP curriculum cuts across traditional
graduate programs in participating schools, divisions and departments. GTP students
take graduate core courses in Genetics and Quantitative Methods and participate in a
weekly journal club during graduate years 2-4. The journal club includes rotating topics
in contemporary genetics or classic, landmark papers relevant to the intellectual
development of the field. GTP students select quarterly topics in consultation with
participating faculty. Journal club papers and discussion are used to assess methods
and logic, experimental design, data analysis, and responsible conduct of research in
additional to the quarterly research topics around which they are selected. A program-
wide annual retreat, organized by year 5 students and an Associate Director, includes
invited outside keynote speakers and research presentations by program faculty and
students. GTP has 30-40 students in training at any one time, for whom we are
requesting 16 training grant slots to support 8 students per class year for two years each.
Intended and realized trainee outcomes are fulfilling scientific careers in academic,
government, and private industry.

Public health relevance
The UCSD Genetics Training Program rigorously prepares an exceptional pool of students for professional careers in basic and applied research in life and health sciences. Our graduates succeed in academic institutions, non-profit research institutions, government agencies, biotechnology and pharmaceutical companies, and related industries that promote human health or scientific advancement. The overwhelming majority of our graduates remain in research-intensive or research-related careers that aim to promote and improve human health.